Elucidating the mechanisms that enable translation in bacterial and eukaryotic ribosomes

Project Summary
As the sole producer of proteins in the cell, the ribosome is central to all cellular life. With this critical role,
ribosome dysfunction can give rise to a host of human disease, which makes it a target for therapeutics. In
addition, since ribosomes are organism-specific, several classes of antibiotics function by halting protein
synthesis in bacteria, without interfering with the dynamics of human ribosomes. However, efforts to combat
bacterial infections face multiple challenges, including antibiotic resistance and side effects. Accordingly, a
thorough understanding of bacterial and eukaryotic ribosome dynamics can be used to design more effective
antibiotics, as well as provide insights into the molecular origins of various diseases. In the current project, we
will apply state-of-the art molecular simulation methods to study how ribosomes are able to accurately and
efficiently produce proteins in the cell (i.e., translation). We will apply multiple types of simulation techniques to
obtain atomistic insights into the dynamics of the conformational rearrangements that enable translation. These
calculations will elucidate the precise interactions that control ribosome kinetics in bacterial and human
ribosomes (cytosolic and mitochondrial). These studies will advance our understanding of ribosome dynamics,
which will allow for more effective therapeutic strategies to be developed, in order to combat bacterial infections
and disease. We will work towards this objective by pursuing multiple avenues of investigation. In collaboration
with experimental groups, we will design and execute simulations that will specifically guide the development of
next-generation single-molecule methods. Our models will also be used to understand the precise relationship
between small-scale conformational motions (identified by nuclear magnetic resonance experiments) and large-
scale/long-time dynamics in the ribosome. We will also use computational strategies to identify candidate small
molecules that may serve as novel broad-spectrum antibiotics. Promising antibiotic candidates will then be
characterized through biochemical, single-molecule and structural biology (cryoelectron microscopy) analysis,
performed in well-established experimental laboratories. Finally, our collaborations with structural biology
laboratories will allow us to provide the first insights into the dynamics of newly-identified functional states. In
addition to immediate therapeutic applications, this broad range of efforts will help establish a comprehensive
understanding of ribosome dynamics that connects experimental observables and theoretical principles, such
that guiding principles may be identified.

Public health relevance
Project Narrative This line of study will use novel all-atom models to perform simulations of ribosomes from various organisms. One goal is to determine which interactions govern the dynamics, which can provide insights into ribosome- related diseases. In addition, by comparing bacterial and human ribosome dynamics, we aim to identify novel strategies for antibiotic design.